Leadership, Planning and Evaluation

PROJECT SUMMARY
LEADERSHIP, PLANNING, & EVALUATION
Center Director Dr. John Cleveland, with the support of his senior leadership team, sets the scientific direction
of the Moffitt Cancer Center (Moffitt) and oversees ongoing rigorous and inclusive planning and evaluation
processes. This led to development of a new Research Strategic Plan (RSP), changes in leadership structure,
revised Aims across all five research Programs, and restructuring/expansion of six Shared Resources previously
rated as Outstanding or Exceptional. Expanding on Moffitt’s mission “to contribute to the prevention and cure of
cancer,” the goal of the RSP is for Moffitt to be the best place for cancer science, recruiting and retaining the
best talent, out-competing for grant funding, and achieving international recognition for impact it has on changing
paradigms, clinical and public health practice, and policy. To accomplish this, RSP focuses on Catchment Area;
Health Disparities; Immuno-Oncology; Metabolism; Data Science; and Cancer Care Delivery, Prevention, and
Implementation Science through three pillars: Optimizing Intellectual Capability, Creating Fuel for Discovery, and
Generating Impact. With significant input from Program Leaders, all Members, and staff completed list of
objectives that was reviewed and prioritized by REX, who aligned research resources and determined priorities
to support the research Programs, including recruitment, mentoring, pilot funding, and collaboration.
Leadership, Planning, & Evaluation (LPE) incorporates the; 1) Research Executive Committee, which is
comprised of Dr. Cleveland and the 8 Associate Center Directors; 2) Scientific Leadership Committee, which
consists of 8 Program Leaders, 4 Center of Excellence Directors, and Research Department Chairs; 3) 8 SLC
subcommittees; 4) 14 Shared Resource Advisory Committees; 5) 2 Community Advisory Boards (CABs); 6)
External Advisory Committee (EAC); and 7) ad hoc internal or external advisors that are added as needed.
Importantly, this collaborative structure, organized by the following Specific Aims, led Moffitt through significant
leadership changes and the COVID-19 pandemic with an undiminished, and indeed accelerated, trajectory.
Aim 1: To develop, implement, and review a dynamic Research Strategic Plan that drives research and growth.
Aim 2: To consult external experts and leaders to evaluate progress and future research priorities.
Aim 3: To operate an effective planning and evaluation infrastructure that enhances efficiencies, and that fosters
collaboration, innovation, and strategic growth.
Over the past cycle, LPE impact included; development of the new RSP; creation of the COEE and RET Offices;
engaging successful leadership succession plans; revising the research Programs to enhance scientific impact;
restructuring/expanding six Shared Resources rated as Outstanding or better; recruiting 72 top-tier research
faculty; awarding pilot grants totaling $10.4M that led to $44.1 in external peer-reviewed funding ($47.4M total
funding); fostering 3,279 publications (24.2% intra- and 18.7% inter-programmatic) of which 543 were in high
impact journals; and stimulating 5,471 therapeutic intervention accruals (5,716 accruals including affiliates).